Human-centered Design and Communities of Practice to Improve Delivery of Home-based TB Contact Investigation in Uganda

PROJECT SUMMARY/ABSTRACT
Household contact investigation is an evidence-based, WHO-recommended approach to finding undiagnosed
patients with tuberculosis (TB) that is now being implemented in high-burden, low-income countries. During the
current award period, we have identified major gaps in the delivery of TB contact investigation in Kampala,
Uganda; characterized these gaps in behavioral terms; and designed, implemented, and evaluated a theory-
informed strategy targeting these gaps in a household-clustered, randomized trial. Unfortunately, the strategy,
“home-based” TB contact investigation, was not effective in increasing either TB evaluation or diagnosis,
although contacts and health workers both preferred it. Fidelity of delivery of the intervention's core
components – home HIV and TB testing and results reporting via text messaging – was low, suggesting a need
to refine the models of delivery. Human-Centered Design (HCD) offers a novel approach to improving the fit of
interventions to household members using co-creation, rapid prototyping, and iterative testing to identify more
engaging delivery solutions. Communities of Practice – close networks of professionals that form to provide
peer support and share tacit knowledge – are increasingly recognized as resources to promote and sustain
quality in health care. Therefore, we propose to collaborate with IDEO.org, a global innovator in Human-
Centered Design, to refine the delivery of home-based TB contact investigation. We will also engage lay health
workers using Communities of Practice to adapt and sustain delivery of core intervention components. We will
then evaluate the refined implementation strategy in a stepped-wedge, cluster-randomized trial in six urban
Ugandan communities not involved in the HCD refinements. We will determine if the HCD-refined strategy –
home-based TB contact investigation delivered via lay health worker communities of practice – improves the
quality, yield, and sustainability of household TB contact investigation relative to a standard strategy. Finally,
we will carry out a detailed process evaluation with nested mixed-methods studies to assess fidelity/adaptation,
sustainability, and their determinants, as well as an economic evaluation (including empirical costing) to
determine cost and cost-effectiveness. We will carry out this work with programmatic partners in the real-world
environment provided by the Uganda TB Implementation Research Consortium. Our well-established team of
investigators has relevant methodological experience (Human-Centered Design, implementation science,
biostatistics, mixed-methods, economic evaluation) and content expertise (HIV, TB diagnostics and contact
investigation, mobile technology). This research will make a significant contribution to public health by
determining if, how, and why novel, patient-centered models for delivering household contact investigation in
low-income countries are effective, efficient, sustainable, and cost-effective. We will also produce generalizable
knowledge about the value of Human-Centered Design and Communities of Practice as tools and methods for
improving fit and delivery of implementation strategies in low-income settings.

Public health relevance
PROJECT NARRATIVE Screening household members of new tuberculosis (TB) patients in low-income countries could help find many TB patients who would otherwise be missed. Currently, however, the yield of this strategy is low. In this project, we will learn if, how, and why two exciting new tools – Human-Centered Design and Communities of Practice – can be used to transform how we find, treat, and prevent TB in households in low-income countries.